Simultaneous Imaging of Tissue Biochemistry and Metabolism associated with Biomechanics in Patella Femoral Joint Osteoarthritis

ABSTRACT
The overall goal of this Supplement to Promote Diversity in Health-Related Research is to provide
training and support to a promising aspiring scientist (Mr. Hector Carbajal Mendez, PhD student in
Bioengineering) in an innovative and productive research environment. Mr. Carbajal Mendez is a brilliant
engineer with interests in using IMU’s to better understand joint loading. This interest directly align with
my labs focus on joint health in subjects with knee osteoarthritis (OA). Specifically, patellofemoral joint OA
is a major source of pain and dysfunction. A hypothetical model for OA pathogenesis has been proposed whereby
repetitive joint loading causes an initial increase in bone remodeling, which is associated with increased vascular
invasion of the deep layers of cartilage. Emerging Proton Emission Tomography and Magnetic Resonance
Imaging simultaneous systems (PET-MRI) offer an exciting new modality to simultaneously acquire numerous
functional measures as well as high-resolution morphology to study this complex phenomenon. Joint loading is
integral to OA progression yet currently, very little is known regarding the biomechanical factors associated with
PFJOA progression. Therefore, our overall goal is to: (i) identify cross-sectional and longitudinal local patterns
of cartilage and bone interactions unique to PFJOA, and (ii) determine the mediation effects of gait biomechanics
and bone morphology on PFJOA progression. We will conduct a longitudinal cohort study investigating 100
people with isolated PFJOA, followed for 2 time points. Simultaneous PET-MRI and gait biomechanics will be
collected for all subjects at baseline and 2-year follow-up. Aim 1: To study the cross-sectional relationships
between bone and cartilage imaging biomarkers and to investigate how the patterns of interactions are
mediated by gait biomechanics and bone morphology.
Hypothesis 1: Elevated SUV in subjects with PFJOA will be colocalized with prolongation of T1ρ and T2 relaxation
times. Complex bone-cartilage interactions mediated by change in loading as a result of abnormal gait
biomechanics and bone morphology will show non-colocalized associations between bone and cartilage.
Aim 2: To study the longitudinal relationships between bone and cartilage imaging biomarkers and to
investigate how the patterns of interactions are mediated by gait biomechanics and morphology:
Hypothesis 2: Early changes in bone metabolic activity (SUV) are a precursor to cartilage compositional changes
(T1ρ and T2). Subjects with specific abnormal gait biomechanics and bone shape features will show accelerated
compositional changes. Aim 3: To determine the ability of bone-cartilage interactions to predict
longitudinal trajectories of structural and symptomatic PFJOA progression. Hypothesis 3: Both colocalized
and non-colocalized bone-cartilage interaction patterns mediated by joint biomechanics and bone shape will be
significant predictors of structural and symptomatic PJOA progression.

Public health relevance
NARRATIVE The overall goal of this Supplement to Promote Diversity in Health-Related Research is to provide training and support to a promising aspiring scientist (Mr. Hector Carbajal Mendez, PhD candidate in Bioengineering) in an innovative and productive research environment. Our overall goal of this scientific project is to identify cross- sectional and longitudinal local patterns of cartilage and bone interactions unique to patellofemoral joint osteoarthritis and determine the mediation effects of gait biomechanics and bone morphology on disease progression.